Training Grant In Tumor Biology

The overall mission of the Tumor Biology Training Program (TBTP) at Georgetown University
(GU) is to provide our pre-doctoral trainees with in-depth knowledge and understanding of the
basic molecular mechanisms that underlie tumor initiation and progression, as well as with the
basic principles of cancer therapy and its translational applications. This highly successful
graduate training program is the only NCI-funded pre-doctoral training program at Georgetown
University (GU) and is the only GU training program dedicated to cancer research. The goal of
the program is to provide not only a rigorous training platform, but also T32-dedicated
research/training resources, including a personalized program for career development deeply
integrated into numerous educational and networking opportunities. This renewal application
incorporates a new leadership structure with the addition of Dr. Chunling Yi as part of a multi-PI
team with the current PI, Dr Anna Riegel. We request support for 6 predoctoral trainees who will
participate in an individualized training program consisting of integrated research, course work,
workshops, programmatic activities, exposure to clinical/translational aspects of cancer,
professional/career development, networking opportunities and engagement with cancer
advocates. The 35 TBTP faculty are drawn from the three highly interactive programs, Cancer
Cell Biology (CCB), Cancer Host Interaction (CHI) & Cancer Prevention and Control (CPC) of our
NCI-designated Lombardi Comprehensive Cancer Center (LCCC). These programs reflect
emerging themes in tumor biology, which include an enhanced focus on tumor immunology,
epigenetic regulation, mechanisms of therapy resistance, as well as cancer prevention and
control, especially in under-represented populations. The LCCC integrated environment
stimulates interdisciplinary collaborations, co-mentoring opportunities, and translational
initiatives. The TBTP has experienced much success over its 27-year history. For the next funding
period, we will continue to address the changing landscape of cancer research through constant
assessment and evolution of our program. We have incorporated a number of new initiatives
designed to provide new opportunities for cutting edge research, data analysis, translational
emphaisis and individualized learning coupled with professional development and wellness
support of all our trainees. Going forward we have also enhanced our rigor and reproducibility
and mentor training and have established an Advisory Committee for Diversity & Inclusion. We
will continue to challenge ourselves in all aspects of TBTP training consistent with the NCI mission
of “supporting cancer research across the nation to advance scientific knowledge and help all
people live longer, healthier lives.”

Public health relevance
The Tumor Biology Training Program (TBTP) is designed to prepare the next generation of dynamic, diverse cancer researchers with lifelong learning skills so that they can make significant inroads into the understanding, prevention and treatment of cancer and to advance scientific knowledge so that all of our cancer patients can live longer and happier lives.